Weight Bias Reduction Intervention with Nursing Students Using Simulation: The BRAVE Study

PROJECT SUMMARY/ABSTRACT
Longstanding evidence documents the detrimental effects of provider biases on poor patient outcomes. Weight
bias among nurses is an understudied concept that causes increased morbidity and mortality in populations
living with obesity. Specifically, studies show that nurses with weight bias: 1) assume patients' symptoms are
related to obesity and do not further probe underlying causes, 2) are more reluctant to perform preventative
health screenings (such as pelvic examinations, cancer screenings, and mammograms), 3) spend less time
engaging with patients during visits, all of which causes patients to withdraw from the provider, potentially
resulting in difficulty remembering or adhering to provider advice and avoiding future preventative care visits.
Given the increasing rates of obesity in the United States, efforts are direly needed to improve the care
provided by nurses who work with this demographic to thwart preventable health consequences (e.g.,
diabetes, heart disease). Our pilot work showed favorable improvements in nursing students' attitudes and
beliefs toward individuals with obesity following a Weight Bias Reduction (WBR) intervention when
implemented into their clinical course. Gaps remain, however, in: 1) whether WBR interventions can translate
into behavior change in clinical practice and make notable reductions in the weight bias patients are
experiencing, and 2) whether these changes are sustained over time. To fill these gaps, the proposed BRAVE
(Building Respect and Acceptance through Valuing Everybody, WBR intervention) will build on our previous
research to include education on communication skills and empathic competence, as well as utilize simulation
with standardized participants living with obesity. The study design is a cluster-randomized controlled trial
comparing BRAVE to SOL (Standard Obesity Lecture) in reducing weight bias among nursing students (n =
368) and will include follow-up measures to determine the intervention's sustained effects one year later.
Additionally, the broader impacts of this BRAVE intervention can enhance long-term health outcomes with the
potential for improved patient satisfaction while navigating the healthcare system. This may have significant
cost savings in our financially overwhelmed healthcare system. Implementing this project will also strengthen
nursing curricula with a pioneering WBR program as an optimal way of providing healthcare for patients living
with obesity. The project will leverage a robust research team, create a pipeline of nursing students who will be
integrated throughout the entire research project, and will build on the existing simulation infrastructure at
Villanova University to provide transformative and innovative educational simulations for improved clinical care
and subsequent health outcomes. The National Institute of Nursing Research’s mission is to promote and
enhance the health of individuals directly, and this research aligns directly with this goal by seeking to improve
the healthcare experience for persons living with obesity through a BRAVE intervention.

Public health relevance
PROJECT NARRATIVE Weight bias is a pervasive but poorly addressed public health concern that directly targets individuals living with obesity. Implementation of a weight bias reduction intervention within this study will enhance future nurses' attitudes, beliefs, and behaviors toward patients living with obesity who often experience weight-based discrimination during routine hospital visits, resulting in poor patient compliance and avoidance of healthcare and preventative care. Furthermore, with the increase in chronic health conditions and morbidity and mortality accompanying patients living with obesity, effective weight bias reduction interventions among undergraduate nursing students could significantly improve health and patient satisfaction and result in subsequent cost savings in a financially overburdened healthcare system.